EFFECTS OF INDIVIDUAL GENES ON HEMATOPOIETIC CELL DIFFERENTIATION AND FUNCTION

Mice homozygous for lpr (a defect at the fas locus) and gld develop autoimmunity and profound lymphadenopathy characterized by the accumulation of two functionally anergic T cell subsets, a predominant B220+CD4-CD8- (DN) population and a minor B220+CD4+ population. In the past year we examined the cellular requirements for the accumulation of DN T cells and the nature of the block in signal transduction in these cells. In addition, lpr and gld mice were examined for evidence of abnormalities in T cell deletion in the periphery that may relate to the defective expression of the fas receptor. Depletion of CD8+ T cells in vivo and ongoing adoptive transfer of gld lymphocyte subsets into scid mice revealed that: 1) CD8+ T cells are required for the accumulation of DN T cells; 2) the precursors of DN T cells are present in gld BM, LN and spleen; 3) CD4+ and CD4+B220+ T cells do not spontaneously differentiate into DN T cells; and 4) DN T cells do not grow autonomously in scid mice or differentiate into CD4+ or CD8+ T cells. Treatment of mice with mAb to IFN-gamma and TNF-alpha had no effect on the accumulation of DN T cells but greatly reduced the levels of serum anti-ds DNA Ab. Signal transduction studies showed that DN T cells proliferated and secreted IL-2 in response to TCR crosslinking and Ab- mediated ligation of CD28. This response differed quantitatively and qualitatively from that of normal T cells, suggesting that DN T cells have a higher than normal threshold for stimulation but potentially may be able to proliferate in vivo. Stimulation of lpr and gld mice with SEB confirmed that DN T cells can proliferate in vivo, albeit less efficiently than CD4+ or CD8+ T cells. All T cell subsets expressing V-beta-8 were deleted after SEB treatment but the deletion of lpr and gld CD8+ T cells was impaired. On the basis of these and earlier studies, we propose that DN T cells arise from peripheral, previously activated CD4+, CD8+ or CD4+CD8+ T cells that have down-regulated the expression of CD4, CD8 and the TCR and normally would be deleted by a fas-dependent mechanism. We further propose that the fas receptor does not play a major role in the deletion of self or foreign super Ag- reactive T cells in the thymus or in the periphery.